Synaptic Mechanisms of Continuous Theta Burst Stimulation in Depression

PROJECT SUMMARY/ABSTRACT
FDA-cleared repetitive transcranial magnetic stimulation (rTMS) protocols are known to increase cortical excit-
ability in treatment-resistant depression, but for safety and tolerability reasons, many patients receive TMS pro-
tocols designed to “quiet” overactive brain networks. Despite their common clinical and research use, we know
very little of their mechanism of action, and consequently, improvements in such protocols have been limited.
Inhibition induced by continuous theta burst stimulation (cTBS), perhaps the best studied inhibitory rTMS proto-
col, is most likely accomplished through either reducing excitation via n-methyl-d-aspartate receptor
(NMDAR)-dependent long-term depression (LTD), and/or through enhancing inhibition via gamma-aminobu-
tyric acid receptors (GABARs). A knowledge of this mechanism enables us to improve clinical effectiveness, as
we have done previously, with mechanism-guided pharmacologic augmentation of an “excitatory” TMS proto-
col. Thus, the critical barrier to unlocking the potential of cTBS is that its synaptic mechanism remains un-
known.
We will test NMDAR-dependent LTD (Aim 1) and GABAR-mediated inhibition (Aim 2) in the dorsolateral pre-
frontal cortex (dlPFC) of 70 depressed subjects in a 4-arm double-blind randomized crossover study. Arms in-
clude sham cTBS, placebo drug, and active drug and cTBS arms. Pharmacology modulates receptors while
cTBS is delivered and cortical excitability is measured with electroencephalography (EEG)-based TMS-evoked
potentials (TEPs). Functional integration of synaptic changes measured by the dlPFC-dependent n-back neu-
robehavioral task will be a secondary measure.
This approach also overcomes the limitations of studying the healthy motor cortex which has un-
known translatability to plasticity in the dlPFC and depressed brain. It also overcomes the rate-limiting
step to optimizing therapeutic TMS-inhibition to quiet focal brain activity. Results will highlight the path
forward to mechanism-guided pharmacologic augmentation for depression and other disorders such as epi-
lepsy, addiction, anxiety, posttraumatic stress disorder, which require quieting of brain networks.

Public health relevance
PROJECT NARRATIVE Overactive brain networks can cause unpleasant symptoms, such as rumination in depression, but targeted therapies like continuous theta burst stimulation (cTBS), a form of transcranial magnetic stimulation (TMS) can safely and noninvasively “quiet” these networks. Unfortunately, cTBS protocols are modestly effective, in large part, because we don’t understand how it therapeutically changes the brain at the underlying synaptic level. We will address this critical barrier to optimizing cTBS-induced inhibition using pharmacology and neurophysiology in depressed patients at the cortical treatment target, thus paving the way for clinical improvements as we have done previously for other TMS protocols increasing excitation.